Immunologic and Imaging studies with TNF Therapy in Prodromal Synucleinopathies

Project Summary
Immunologic and Imaging studies with TNF Therapy in Prodromal Synucleinopathies is a pioneering,
prospective, randomized, double-blind parallel group study designed to assess the potential of anti-
TNF (adalimumab) to slow or prevent the emergence of motor and cognitive symptoms of synucleinopathy.
The trial is based on data from our ASAP grant where we integrated single-cell genomics analysis and observed
T-cell pleocytosis in the CSF of RBD patients and an increase in circulating inflammatory central memory Th17
cells in RBD similar to other autoimmune diseases. In CSF of RBD and PD patients, we observed increases in
activated non-classical monocytes with upregulated TNFR2 and TNF-mediated signaling pathways indicating
increased CNS inflammation. Core funding for PRISMS was provided by a grant from the Marcus Foundation,
AbbVie is providing drug, and the study is being carried out with the Parkinson Study Group. 100 subjects with
polysomnographically-proven RBD who have not been diagnosed with either PD or DLB will be randomized 1:1
to receive anti-TNF or placebo for two years. In addition to clinical assessments, subjects will undergo
multimodal neuroimaging studies and will be given a body-attached wearable biosensor. The core trial funding
for PRISMS is sufficient to support conduct of site activities, including clinical outcome measures, MRI and
dopamine transporter (DaT) scans, collection of biological samples, trial operations, oversight and regulatory
reporting. In this proposal, we are requesting funding to support novel interrogation of the immune cell
populations (in vivo perturb seq) and clinical imaging. Specifically, we propose to perform: Aim 1)
immunophenotyping with single-cell RNA-Seq, characterization of FoxP3 regulatory CD4 T cells, and evaluation
of the soluble markers of inflammation and neurodegeneration in CSF of a subset of 30 subjects and in blood of
the entire study population; Aim 2) FDG-PET scans for assessment of brain metabolic activity using the statistical
parametric methods, structural integrity of brain dopaminergic systems using Dopamine Transporter SPECT
imaging to evaluate dopamine nerve cell terminals, and neuromelanin-MRI to assess catecholaminergic cell
bodies. While the clinical trial will test the hypothesis that prodromal PD as manifest with RBD is inflammatory
mediated by TNF whether the treatment approach is successful, the proposal will provide deep mechanistic
insight into the role of the TNF pathway in the progression of synucleinopathies.

Public health relevance
Project Narrative PRISMS is a prospective, randomized clinical trial testing the ability of the anti-TNF (adalimumab) to slow or prevent the progression of motor and cognitive symptoms of synucleinopathy in persons with REM Sleep Behavior Disorder with core funding provided by the Marcus Foundation. The design of the study provides the substrate for longitudinal assessments to explore not only the effect of the therapeutic intervention, by performing 1) in vivo perturb seq to identify changes in immune cell function after anti-TNF treatment in CSF and blood using single cell RNA sequencing; 2) characterization immune cell populations, with a focus on FoxP3 regulatory CD4 T cells; 3) evaluation of the soluble markers of inflammation and neurodegeneration in blood and CSF; 4) multimodal imaging studies, including brain metabolic patterns assessed using 18-F Fluorodeoxyglucose (FDG) and integrity of dopamine and catecholamine neurons using Dopamine Transporter (DaT) SPECT and neuromelanin MRI imaging and 5) assessment of motor and cognitive function using sensitive digital health technologies in addition to routine clinical scales. In this proposal, we are requesting funding to support for conducting novel mechanistic studies While the clinical trial will test the hypothesis that prodromal PD as manifest with RBD is inflammatory mediated by TNF whether or not the treatment approach is successful, this project will provide deep mechanistic insight into the role of the TNF pathway in the progression of synucleinopathies.